Immunotherapies for RAN protein diseases

Project Summary
Repeat expansion mutations cause more than 50 neurodegenerative diseases, including Huntington’s disease
(HD) and C9orf72 amyotrophic lateral sclerosis. Despite intense research, there are no effective treatments for
any of these disorders. Repeat expansion mutations are often bidirectionally transcribed and can undergo repeat
associated non-AUG (RAN) translation (1). This process results in the expansion RNAs being translated into
toxic RAN proteins across all reading frames without the requirement for AUG, or AUG-like initiation codons (2).
Because both sense and antisense expansion RNAs can be translated in each reading frame, up to six toxic
proteins can be produced from a single mutation. RAN proteins have been reported to accumulate in disease-
affected tissues of patients for 11 expansion diseases (1, 3, 4), including Huntington’s disease (HD) (5) and
spinocerebellar ataxia type 8 (6) which are caused by CAG•CTG expansion mutations and C9orf72 which is
caused by a GGGGCC•GGCCCC expansion (7-9). There is strong evidence that RAN proteins are toxic and
contribute to a growing number of repeat-expansion disorders and could be an attractive therapeutic target.
Strong preclinical data in C9-ALS BAC transgenic mice show that passive immunotherapy reduced RAN
proteins, improved behavior, increased longevity, and improved neuropathological phenotypes including motor
neuronal survival in C9-BAC transgenic mice (10). While promising, passive immunotherapy comes with many
disadvantages including the expense to produce these antibodies and that patients must receive frequent
injections. The central hypothesis of this proposal is that vaccination against RAN proteins will be an effective
strategy to elicit a beneficial immune response and mitigate disease in C9orf72 ALS and HD mice. I propose to
test this hypothesis by determining if RNA-based liposome vaccines can elicit beneficial immune responses that
reduce RAN protein levels and improve disease in mouse models of C9-ALS and HD.

Public health relevance
Project Narrative Repeat expansions cause more than 50 neurodegenerative diseases, including 11 disorders in which repeat associated non-AUG (RAN) proteins have been found. There is strong preclinical data supporting the hypothesis that RAN proteins are toxic and lowering their levels can improve disease. I will test the hypothesis that RNA- based vaccines against RAN proteins produced in C9orf72 amyotrophic lateral sclerosis (ALS) and Huntington’s disease (HD) can elicit a beneficial immune response that lowers RAN protein levels and mitigates disease.